CE24-001, Injury Prevention Research Center at Emory (IPRCE).

PROJECT SUMMARY
In Georgia, and the U.S., injury is the number one cause of death for persons 1-44 years of age. The Injury Prevention Research Center at Emory (IPRCE) supports research, education and training, and outreach aimed at preventing injury. IPRCE activities are aligned with cross-cutting themes of (1) improving heath of all people (2) supporting communities across that are disproportionately affected by injury, violence and overdose, and (3) promoting/applying implementation (translation) science in the development and delivery of interventions.
IPRCE will provide significant contributions to injury prevention science through the completion of our core research projects which focus on (1) Evaluating the implementation and adoption of a coordinated model for delivering an evidence-based overdose prevention intervention (Naloxone and Fentanyl test strips) across pharmacies, community-based harm reduction organizations, and peer support networks to support individuals at risk for overdose, (2) Characterizing individual, relationship, and community risk and protective factors for suicide for Black men with access to firearms and using these to identify, adapt, and pilot suicide prevention interventions, (3) Characterizing implementation barriers and developing tailored implementation strategies that support the adoption and implementation of coordinated hospital-community trauma-informed care programs that address the needs of violently injured youth.
IPRCE will conduct training that increases sustainability and builds the capacity of public health professionals and practitioners to more effectively identify and deliver evidence-based injury prevention programming. We will support training the next generation of injury, violence, and overdose prevention work force through an injury certificate program, practicums, and internships.
IPRCE will continue to support five volunteer task forces, one targeted at preventing the top five causes of injury death, which include falls, overdose, violence, traumatic brain injury, and motor-vehicle crashes. Through these, IPRCE will engage community partners, support research to practice and practice to research loops, and support injury, violence, and overdose prevention programming across Georgia and the southeastern United States.

Public health relevance
PROJECT NARRATIVE Injury is the top cause of death for persons aged 1-44. To reduce the burden of injury, our center will conduct innovative research that is aligned with CDC NCIPC priorities and that will lead to prevention of opioid overdose, falls, motor-vehicle crashes, violence, and traumatic brain injury. We will train practitioners students, and researchers to build capacity for injury prevention among these groups; and conduct innovative outreach that improves the knowledge, skills, and communication abilities of injury prevention students, practitioners, and researchers.